Development and Maintenance of Human and Animal Food Rapid Response Teams

Abstract: Tennessee Rapid Response Team Application 2023
The Tennessee Rapid Response Team (TNRRT) will work with the Food and Drug
Administration (FDA), the Tennessee Department of Health (TDH) State Public Health
Laboratory (SPHL), the Tennessee Department of Agriculture (TDA), the University of
Tennessee (UT) Agriculture Extension, and the TDH Foodborne Enteric Diseases (FED)
Program, in a collaborative manner. TDH believes that the past and continued success of its
enteric outbreak response structure is reliant on having strong relationships with these partners.
We will leverage our existing relationships to collaborate with organizations/programs
contributing to the success as a RRT member within Tennessee, e.g., the Environmental Health
Specialist Network (EHS-Net), Foodborne Disease Active Surveillance Network (FoodNet),
Foodborne Diseases Centers for Outbreak Response Enhancement (FoodCORE), Integrated
Food Safety Centers of Excellence (CoE), and the Association of Food and Drug Officials
(AFDO), and FDA.
TDH strives to be a leader in the area of foodborne illness investigations and environmental
health. TDH is an active voluntary RRT state and fully supports the goals and projects of the
national RRT mission by integrating activities within the state. We have been a voluntary RRT
site since 2018 and place a high priority on activities which foster the collaborative RRT
network. Since 2018, the TNRRT has participated in monthly RRT meetings, annual RRT
conferences, and the environmental assessment addition to the RRT Best Practices Manual
workgroup.
We believe that becoming a fully funded RRT will improve our ability to fully develop the RRT
structure, cultivating our existing outbreak response metrics. Our activities foster a collaborative
network between a range of programs in Tennessee and nationally. These programs and
activities will work synergistically with the TNRRT and RRT consortium members. This
application will demonstrate our TNRRT development objectives, our voluntary TNRRT
activities, and how we can leverage our existing structure to fully develop an effective RRT in
Tennessee.

Public health relevance
Narrative: Tennessee Rapid Response Team Application 2023 The Tennessee Department of Health strongly desires to continue work with the Food and Drug Administration’s (FDA’s) Rapid Response Team (RRT) consortium. Since 2018 we have been a voluntary RRT member and recognize our mission is aligned with the stated purposes and objectives in the Development and Maintenance of Human and Animal Food Rapid Response Teams funding opportunity. We believe that becoming a funded RRT will improve our ability to fully develop the RRT structure, cultivating our existing outbreak response metrics. We have proposed a plan that we feel can enhance our ability to respond to human and animal food emergencies by completely enacting the FDA RRT framework in Tennessee. Our activities will foster a collaborative network between a range of programs in Tennessee and nationally.